Oxygen Activation by Mononuclear Copper(I) Active Sites

Project Summary/Abstract. The interactions of coupled binuclear copper sites and dioxygen have been extensively studied in contexts crucial to life. This contrasts with analogous interactions between mononuclear copper sites and dioxygen, which are less well understood despite their importance in clinical, biological, and industrial settings. As such, furthering our understanding of these enzymes' mechanisms of action would have far reaching implications across a wide set of disciplines. This project focuses on mechanistic elucidation of the oxidative behaviors of three different monooxygenases featuring single copper active sites: tyramine β-monooxygenase (TβM), lytic polysaccharide monooxygenase (LPMO), and particulate methane monooxygenase (pMMO). The first, TβM, is closely related to human dopamine β-monooxygenase (DβM) and participates in invertebrate neurotransmitter regulation. As a noncoupled binuclear copper enzyme, it features two copper centers separated by 11 Å, only one of which engages with O2. Outstanding questions on the timing of O2 binding to the reduced enzyme, hydrogen atom abstraction (HAA), and intermetallic electron transfer persist. The second enzyme, LPMO, has large industrial applications in renewable biofuels and has also been implicated as a virulence factor in several pathogens. Its active site comprises a single copper ion coordinated to two histidine residues and the N-terminal amine in a rare histidine brace geometry. Computational results inform the planned experiments, suggesting several mechanistic possibilities; though, some recent reports have questioned the role of O2 in favor of H2O2. The last enzyme, pMMO, is important in conversion of methane, a dangerous greenhouse gas, into methanol, a renewable fuel. It has long been thought to possess a coupled binuclear copper active site, but has recently been reappraised to have a mononuclear copper site also engaged in a histidine brace structural motif. This new suggestion means there is little mechanistic insight available, though it draws parallels between pMMO and LPMO. The project ultimately aims to shed light on how these enzymes oxidize their substrates, and to uncover useful and generalizable structure-function relations to be exploited in further clinical and industrial applications. Our specific aims involve investigation of each class of enzyme using a battery of spectroscopies to uncover informative intermediates, capitalizing on the extensive instrumentation and experience available in the Solomon lab. As many of these transformations involve paramagnetic species, electron paramagnetic resonance (EPR) and magnetic circular dichroism (MCD) experiments will allow direct interrogation of the copper center, particularly in combination with rapid freeze quench (RFQ) techniques. Additionally, stopped ow absorption, resonance Raman (rR), X-ray absorption (XAS), and X-ray emission (XES) will be heavily employed, especially when studying diamagnetic states. All of these studies will be supported by thorough computational investigations using density functional theory (DFT) methods, which will allow for further insight into the electronic structures and reaction energies. The training plan involves immersion in these spectroscopic techniques and in the field of bioinorganic chemistry, all of which are new to the applicant.

Public health relevance
Project Narrative. Interactions between copper and dioxygen in enzymes mediate a wide variety of essential biological functions; yet, the underlying O2 chemistry of monocopper enzymes remains poorly characterized in terms of their mechanism and interactions with substrate, particularly in comparison with coupled binuclear copper enzymes. These mononuclear species comprise many important enzymes, including dopamine/tyramine β-monooxygenase (DβM/TβM), involved in oxidative transformations of neurotransmitters, lytic polysaccharide monooxygenases (LPMOs), involved in oxidative degradation of polysaccharides, and arguably particulate methane monooxygenases (pMMOs), involved in methane oxidation to methanol. This project centers around mechanistic elucidation of the catalytic cycles of TβM, LPMO, and pMMO through direct spectroscopic observations of enzyme intermediates to gain more detailed insight into their roles in neurochemistry, pathogen virulence, and the oxidative degradation of organic matter.